Coordinated resident macrophage-tenocyte signaling in tendon formation

Summary
Despite the vast knowledge of the structure and mechanical function of mature tendons, the understanding of
tenogenic cell differentiation during development and how cell types from non-tenogenic origins, such as
macrophages, influence tenogenesis is limited. Tissue resident macrophages play key roles in the development
of several tissues and colony stimulating factor 1 receptor (CSF1R) signaling is essential for their differentiation
and survival. The source of ligands that act on CSF1R (CSF1 being the most common) often originate from
adjacent resident cells. In addition to CSF1R signaling acting on the macrophages, macrophages often produce
trophic factors that act on the adjacent resident cells to regulate aspects of tissue development. In exciting new
data, we demonstrate that CSF1R-expressing resident macrophages are situated adjacent to CSF1-expressing
tenocytes within linear arrays in the tendon fascicle from initial formation (E15.5) into adulthood, these resident
macrophages rapidly accumulate to nearly 10% of the total cell population within tendons during early postnatal
growth, and CSF1 produced by tenogenic cells is required for their survival. Additionally, these macrophages
internalize collagen in situ, which may indicate a potential role in matrix remodeling during growth and
development. Despite their relative abundance and presumed communication with adjacent tenocytes, our
limited understanding of the role of resident macrophages in tendon growth and development and potential
trophic signaling to tenocytes are significant gaps in knowledge. As macrophages are critical to the development
and repair of numerous tissues, defining their role in tendon development will provide insight into signaling
mechanisms that could be leveraged in future therapies to improve repair outcomes, which is an unmet clinical
need. To address these gaps in knowledge, this proposal will define the ontogeny, distribution, and phenotypic
profile of resident macrophages and establish their cross-talk with tenocytes to regulate tendon formation during
growth and development. Our central hypothesis is that stable macrophage-tenocyte cross-talk exists and this
communication is necessary for tendon formation. Aim 1 will define the ontogeny, abundance, and distribution
of resident macrophages with respect to Csf1-expressing tenocytes and the phenotypic profile of these cells at
multiple stages of growth and development. Aim 2 will then establish the cross-talk between macrophages and
adjacent tenocytes and its role in tendon formation and growth. In this proposal, we will elucidate the importance
of stable macrophage-tenocyte cross-talk in promoting cell differentiation and tendon formation in growth and
development, thus providing new and critical insight to tendon cell biology that will inform future regenerative
strategies.

Public health relevance
Narrative Despite the vast knowledge of the structure and mechanical function of mature tendons, the understanding of tenogenic cell differentiation during development and how cell types from non-tenogenic origins, such as macrophages, influence tendon formation is limited. Tissue resident macrophages play key roles in the development of various tissues and colony stimulating factor 1 receptor (CSF1R) signaling is essential for their differentiation and survival. This proposal aims to fill this gap in knowledge by defining the ontogeny, distribution, and phenotypic profile of tendon resident macrophages and establish their communication with tenocytes to regulate tendon growth and development.